Leveraging Unique Capabilities and Capacities for Chemical Analyses of Diverse Food and Feed Matrices in Support of an Integrated Food Safety System

Admin Core Project Summary The California Animal Health and Food Safety Laboratory System (CAHFS) is California’s state veterinary diagnostic laboratory, responsible for assuring the health of the state’s agricultural animals and safety of foods of animal origin. The CAHFS Toxicology Section occupies a unique position as a highly experienced and well-equipped veterinary toxicology laboratory and is a natural fit as a partner to the FDA in furthering their mission of protecting human food and animal feed in the U.S. from unsafe chemical contamination. Careful and thoughtful management of the grant projects and their budgets is the only means by which the successful performance of the proposed food defense, surveillance sample analyses, and method development and validation projects will be achieved. CAHFS proposes to ensure project success by assisting and enabling personnel of the CAHFS Toxicology Section to perform the work required by providing the resources of time, equipment and managerial support. Management and administration of the grant will occur through the cooperation of the CAHFS Toxicology Section with CAHFS administrative personnel who, under the guidance of the University of California, Davis, Office of Research, Sponsored Programs office, will provide budget oversight according to FDA and University of California guidelines. The grant PD/PI, the CAHFS Toxicology Section Chief Chemist/Laboratory Manager, and CAHFS Toxicology Section Senior Chemists will coordinate and manage the work assignments, ensure adherence to project time lines and due dates, report results, and produce reports required by the grant.